New Synthetic Methods Enabled by Excited-State Redox Chemistry

Project Summary
The work described in this proposal aims to develop novel synthetic methods that address longstanding
challenges in organic synthesis and catalysis. A primary goal of this work is the development of non-equilibrium
synthetic methods enabled by excited-state redox events. These technologies provide opportunities to use
photon absorption events to drive reaction against a thermochemical gradient, but without requiring generation
of excited state substrates. Importantly, these methods provide novel approaches to achieve non-Boltzmann
product distributions and reaction outcomes that are not, by definition, possible to obtain using conventional
ground-state methods. Applications to the light-driven deracemization of ketones and asymmetric contra-
thermodynamic olefin isomerizations are presented. An additional focus is the continued development of proton-
coupled electron transfer (PCET) technologies for use in organic synthesis. In particular we present a new PCET-
based method for the redox-neutral cleavage of aliphatic C-C bonds in amino alcohols. The resulting amino-
carbonyl complexes can be directly converted in situ to valuable ring-expanded cyclic amines or lactams.
Analogous methods are presented for the conversion of cyclic 1,2 diols into cyclic ethers and lactones. We also
propose to develop an improved and general PCET-based protocol for the anti-Markovnikov hydroamination of
unfunctionalized olefins with sulfonamides, which accommodates a much wider scope of amine derivatives than
our previous methodology. We will also develop PCET-enabled transformations of hydrazones, including Wolf-
Kishner type deoxygenations under neutral conditions at room temperature and the ring-contraction reactions of
cyclic pyrazolines to form cyclopropanes and other small-ring products. Lastly, we will expand the scope of our
PCET-based methods for the nucleophilic aromatic substitution reactions of phenol via transient phenoxyl radical
intermediates with respect to both the nucleophilic and electrophilic components. If successful, these efforts will
provide valuable new transformations and reactivity concepts for the chemistry communities engaged in the
discovery, synthesis, and manufacture of pharmaceuticals and other small-molecule probes of biological
function, and thus create a significant benefit to human health.

Public health relevance
Project Narrative In this proposal, we describe the development of new synthetic methods and photocatalytic processes that are enabled by excited-state redox chemistry. This work aims to provide solutions to significant and long-standing gap in the synthetic literature and provides a basis for the development of novel methods to enable the construction of both complex targets and common pharmacophores. The reactions and processes enabled by these technologies will provide new tools to simplify the discovery, design and manufacture of drugs and other small molecule probes of biological function, creating a significant benefit for human health and the associated biomedical sciences.